Integrative Prioritization of Alcohol and Drug-Addiction Related Genetic Loci

PROJECT ABSTRACT
The discovery of genetic risk factors for alcohol and tobacco use and dependence has largely focused on the
contribution of individual genetic markers, such as single nucleotide polymorphisms (SNPs). While this approach
has been useful in mapping the genetic liability of rare diseases with a Mendelian pattern of inheritance, the
approach has had limited success with complex diseases characterized by a more polygenetic architecture. The
identification of a set of genetic factors that account for individual differences in the liability to use and misuse
alcohol and tobacco/nicotine will be a major step in understanding mechanisms of undercontrolled use.
Moreover, the development of novel resources to predict or infer risk for problematic use of alcohol and tobacco
based on genetic factors that largely explain individual differences in alcohol and tobacco use/problems, as well
as other behavioral or neurocognitive phenotypes, will be a major step in translating research discoveries into
prevention strategies. The current proposal addresses the problem of limited predictive power in alcohol and
tobacco/nicotine genetic studies by proposing novel research that uses an integrative approach and existing
data and bioinformatics resources to: (1) localize genetic variants that comprise the additive genetic effects on
alcohol and tobacco use and dependence, and (2) developing a novel and freely-available resource that
enhances the way existing genetically informed samples are used for alcohol and tobacco risk prediction. The
current application assembles a multidisciplinary team of molecular genetics and computational and statistical
geneticists to execute these project aims.

Public health relevance
PROJECT NARRATIVE The current application seeks to overcome limitations observed in genomewide association studies of alcohol and tobacco use and disorders (ATUDs) by using novel approaches and existing data to (1) localize genetic variants that comprise the additive genetic variance of ATUDs and (2) develop new technologies to enhance risk prediction for alcohol, tobacco, and related complex traits. Gene sets identified by this project will serve as a resource that highlights to the biological underpinning of alcohol and tobacco use and disorders.